BRAIN IMAGING IN ALCOHOLICS WITH ORGANIC BRAIN SYNDROMES

Various in vivo imaging methods are being used to study the brains of alcoholics with organic brain syndromes. These techniques enable comparisons of gross anatomy (CAT-Computed Axial Tomography; MRI - Magnetic Resonance Imaging) of the brain with electrical activity (EEG - electroencephalography; ERPs - Event-Related Potentials) and rate of glucose utilization in specific regions (PET - Positron Emission Tomography). From a clinical perspective, these techniques, in association with other diagnostic tests, enable qualitative judgments to be made as to the anatomic and physiologic integrity of the brain.